The Molecular Underpinnings of Complex Social Behavior

Humans are highly social. Our brains have evolved to recognize and interpret the expression of
faces and to produce and process language. Our behavior is modulated by our social
interactions, and defects in social cognition manifest themselves in various disorders, including
depression and autism. However, it has remained challenging to model these conditions in
classic genetic systems such as rodents and flies because they only display basic social
behaviors. Social insects such as ants, on the other hand, have evolved sophisticated societies
and social behaviors, including nestmate recognition and complex communication via chemical
cues. Their behavior is contingent on the social environment, giving rise to cooperation and
division of labor. We study ants to understand the basic genetic and neurobiological
mechanisms underlying these phenomena. Because most of the molecules that modulate social
behavior, such as neuropeptides, biogenic amines, and epigenetic marks on DNA and histones
are conserved from insects to mammals, many of the insights gained from ants will also be
applicable to humans. Over the past five years we have developed tools for the clonal raider ant
Ooceraea biroi, a species that combines complex social insect biology with unprecedented
experimental control. We can now monitor social behavior using computer vision, measure,
map, and pharmacologically manipulate candidate neuromodulators in the ant brain, and create
stable gene knockout and transgenic lines using CRISPR technology. We will study the
development, organization and activity of the ant antennal lobe, the part of the brain that
processes the ants' sophisticated chemical language. We will also conduct a large unbiased
screen to identify candidate neuromodulators that affect social behavior. We will then
manipulate these candidates pharmacologically and genetically to describe their function in
more detail. We will also genetically disrupt DNA methylation, a common epigenetic mark
implicated in behavioral individuality and plasticity. Finally, we will study how communication
and social behavior affect the performance of social groups in dynamic and challenging external
environments. This work will elucidate how, on a molecular level, the brains of social partners
interact. This work is innovative because it uses a novel and uniquely suited study species to
take a complementary approach to important biological questions of biomedical relevance. It will
produce additional tools and resources to further establish the clonal raider ant as a model
system for behavioral genetics, and it will shed light on the molecular mechanisms underlying
social behavior, which can then be studied further in other species including humans.

Public health relevance
Project Narrative Neurodevelopmental and mood disorders that entail severe social impairments such as autism and depression have been difficult to model in available genetic study systems due to a lack of complex social cognition. The proposed research will use the clonal raider ant Ooceraea biroi as a complementary model system to study the genetic and neurobiological underpinnings of complex social behavior with an array of available molecular tools and behavioral assays. Given that many of the neuromodulators regulating social behavior are likely conserved between insects and mammals, this work will identify and characterize candidate molecular mechanisms that can then be studied further in other organisms, including humans.